The roles of Lyme spirochete adhesins in hematogenous dissemination

Upon transmission by a vector tick bite, Lyme disease spirochetes, primarily B. burgdorferi (Bb) in the US,
establish a local skin infection, then disseminate to multiple tissues. Chronic infection by Bb is often associated
with arthritis. Our laboratories have identified and/or characterized many Bb cell- or extracellular matrix (ECM)-
binding adhesins using multiple approaches, overcoming the challenges of defining their roles in Bb biology.
Our approaches include analyses of biochemical activities and generation of targeted mutants selectively
defective for a single adhesive activity and analysis of the mutants in multiple murine infection models. To gain
detailed mechanistic insight into interactions that may occur during Bb dissemination in vivo, following
intravenous inoculation we used intravital microscopy to characterize vascular attachment and transmigration
in skin and joint-proximal tissue. These studies revealed that adhesins BBK32 and VlsE account for virtually all
of the transient Bb-endothelium binding occurring minutes after inoculation, termed “Meeting” interactions. A
distinct set of adhesins, DbpB/A, OspC, and P66, mediate contacts required for invasion into extravascular
joint space after 24 hours (hr), termed “Transmigrating” interactions. Using isogenic strain sets that have
acquired or lost specific adhesive activities in multiple short-term and long-term infection models we showed
roles for five of the six Meeting or Transmigrating adhesins in short-term tissue localization and/or long-term
colonization in other murine infection models. While Transmigrating adhesins do not promote “Meeting”
interactions, our discovery of enhanced adhesive capacity of the endothelium as infection progresses has
helped clarify why different adhesins have roles at different stages of infection. Within hr, “Endothelial
Activation” permits BBK32- and VlsE-independent (“Greeting”) interactions. After ~24 hr “Endothelial
Potentiation” occurs, reflected by the ability of the joint vasculature to support Bb transmigration. Although both
OspC and P66 function as Transmigrating adhesins, only P66, an integrin-binding adhesin that alters
transcription in cultured endothelial cells, is also Potentiating, i.e., required to promote the rapid transmigration
of a second Bb strain. Activation is mimicked by exogenous treatment of mice with several cytokines produced
by infected mice, but potentiation is seen only with TNF-α, MCP-1 or IL-10. These findings reveal previously
unrecognized steps that are critical for Bb spread and provide a means to distinguish roles for each adhesin in
distinct infection stages: Meeting, Greeting, Potentiating, Transmigrating and Colonizing. In Aim 1 we will
identify known adhesins that facilitate Greeting interactions; to better prioritize our adhesin list, we propose a
genome-wide screen that may also identify novel adhesins. In Aim 2 we will clarify the roles of known (and, if
applicable, novel) adhesins in endothelial Potentiation and Transmigration. Our use of rigorous genetic
analyses in infection models from visualization of key interactions in vivo to quantitative analysis of Bb at
different stages of infection will result in detailed understanding of a critical facet of Bb biology: dissemination.

Public health relevance
Project Narrative Lyme disease, the most prevalent vector-borne illness in the Northern Hemisphere, is continuing to expand in geographic range and case numbers, and a significant burden on the health system in endemic regions. The causative organism, Borrelia burgdorferi, produces a complex array of proteins (adhesins) that bind to mammalian tissue components and that contribute to the ability of the bacteria to cause infection. The three principal investigators together form a team with unique expertise that will allow comprehensive investigations of the functions of B. burgdorferi adhesins in multiple steps of the infection process, including changes in the cells lining blood vessels, a step that allows bacterial escape and invasion of host tissues.